Role of STAT in heterochromatin initiation

Project Summary
Heterochromatin is a tightly packed form of DNA essential for chromosomal compaction, transcriptional
silencing, genome stability, animal longevity, and tumor suppression. The mechanisms behind heterochromatin
establishment remain incompletely understood. This project aims to investigate the initiation of
heterochromatin, focusing on the interplay between Heterochromatin Protein 1 (HP1) and Signal Transducer
and Activator of Transcription (STAT). Our previous research has shown that a fraction of STAT, not
phosphorylated at the critical tyrosine residue around amino acid 700 (uSTAT), localizes in the nucleus in
association with HP1. We demonstrated that STAT is essential for heterochromatin maintenance and that its
activation by phosphorylation disrupts heterochromatin. Additionally, human uSTAT5A and STAT3 have been
shown to promote heterochromatin formation and suppress tumor growth. Preliminary studies using chromatin
immunoprecipitation followed by deep sequencing (ChIP-seq) revealed that a significant amount of chromatin-
bound Drosophila STAT is localized in constitutive heterochromatin. Loss of STAT leads to a global decrease
in the levels of trimethylated histone 3 at lys9 (H3K9me3), a heterochromatin marker. Furthermore, when
uSTAT is forced to bind to euchromatin, it can repress nearby genes in an HP1-dependent manner. These
findings suggest that uSTAT plays a crucial role not only in maintaining but also in initiating heterochromatin
formation. HP1 and H3K9me3 are hallmarks of heterochromatin, with HP1 being the central component. While
recruiting HP1 to euchromatin is sufficient to initiate heterochromatin formation, HP1 does not bind DNA
directly and has a weak affinity for H3K9me3. This suggests that HP1 may require DNA-binding protein factors
for its initial recruitment to heterochromatic loci or to strengthen its binding to H3K9me3. Indeed, protein factors
and RNA molecules have been implicated in heterochromatin establishment. We hypothesize that uSTAT is
among the protein factors required for the establishment of a subset of heterochromatin. We will employ a
combination of genomic, genetic, and biochemical tools to investigate the initial events leading to
heterochromatin establishment. Understanding the molecular mechanisms of heterochromatin establishment
could lead to novel cancer therapeutics through targeted epigenetic gene silencing.

Public health relevance
Project Narrative Heterochromatin is important for multiple cellular processes including chromosomal compaction, genome integrity, transcriptional gene silencing, and tumor suppression. While our previous research has shown a requirement for the JAK/STAT pathway in maintaining heterochromatin, the molecular mechanism of heterochromatin establishment remains unclear. The goal of this project is to elucidate the molecular mechanism by which unphosphorylated STAT plays an essential role in heterochromatin establishment, which could lead to novel cancer therapeutics, e.g., targeted epigenetic silencing of key oncogenes through gene therapy.